Identification of Rare Variants for Orofacial Clefts Using Publicly Available Datasets

PROJECT SUMMARY
Orofacial clefts (OFCs) are the most common birth defects affecting the head and neck. Families with OFCs
face significant financial, educational, medical, psychological, and cultural challenges, including instances of
infanticide due to stigmatization and a lack of sociocultural support. This proposal focuses on two key aims: (1)
identifying craniofacial genes with rare non-synonymous deleterious variants, and (2) identifying craniofacial
enhancers with rare deleterious variants. By identifying rare deleterious variants in craniofacial genes and
enhancers, these aims will advance our understanding of the genetic and molecular mechanisms underlying
oral clefts (OFCs), significantly contributing to the improvement of treatment, prevention, and overall quality of
life for affected individuals and families.

Public health relevance
PROJECT NARRATIVE Orofacial clefts (OFCs) are complex traits that require advanced genetic methods and detailed phenotyping to identify unknown risk variants, which are essential for clinical translation and prevention. In our study, we will use Whole Genome Sequencing (WGS) data from individuals with OFC in African populations and those without OFC from the All of Us database to identify craniofacial genes and enhancers with a significant burden of rare variants associated with OFC. This research aims to identify the mechanisms by which these variants contribute to clefts in individuals of African descent, with potential implications for preventive strategies applicable to other populations worldwide due to the genetic diversity of the African population.